NorthStar Node of the Clinical Trials Network

Project Summary
Since the COVID-19 pandemic, American Indian and Alaska Native (AIAN) adults now experience the highest
rate of drug overdose in the United States, which is 31% higher than that of White adults.1 AI/AN adults are
particularly at high risk for opioid use disorder (OUD) due to elevated risk of chronic health conditions
influenced primarily by social determinants of health, as well as historical trauma.2 Illicit use of opioids is a
major public health problem associated with significant morbidity and mortality related to HIV, hepatitis C, and
overdose.3-5 AIAN adults in Minnesota are seven times more likely to die of an overdose involving opioids than
whites, representing the greatest disparity observed between AIAN and whites in the US.6 Medication for
opioid use disorder (MOUD) is an evidence-based approach,7-9 and strategies to promote the continuation of
pharmacotherapy and support OUD recovery are important.10,11 Gender-specific factors affecting opioid use
relapse and recovery that are more prevalent in women compared with men include perceived stress, trauma,
and enhanced biological stress reactivity; as well as less social support for abstinence.12,13 AIAN gender-
specific interventions for OUD do not exist. Research has documented the positive impact of social networks
and social support on abstinence from substance use.145 However, understanding how best to leverage social
support remains a key challenge for the addictions treatment field.15 In NIDA CTN-0123 (Aim 1) we are
addressing these gaps by developing a social digital (Facebook) intervention to promote stress management
and social network support for opioid abstinence among AIAN women. Especially with the COVID-19
pandemic, virtual digital platforms have potential for greater reach and scale.16,17 Consistent with the AIAN
cultural value of interdependence, social media-formed groups to prevent opioid relapse could lead to greater
adoption and sustainability by encouraging collaborative efforts across generations of AIAN women and
leveraging community resilience for coping with stress.18-21 The overall research objective is to develop and
evaluate the feasibility of a Facebook intervention for supporting recovery from opioid use among AIAN
women. This project was designed with community partners at the MN Indian Women’s Resource Center
(MIWRC). A community advisory committee (CAC) contributed to the development of the Facebook
intervention content and study protocol for Aim 1 (NIDA CTN 0123) and will continue to guide all study
activities for the Aim 2 pilot RCT proposed here.

Public health relevance
PROJECT NARRATIVE Gender-specific interventions among American Indian and Alaska Native women (AIAN) to promote opioid use recovery do not exist. We propose to address this gap by developing a social digital (Facebook) intervention to promote stress management and social network support for opioid abstinence among AIAN women. We will develop and then beta-test the Facebook intervention among AIAN women who are receiving medication assisted treatment for opioid use disorder.